Strategy for specific delivery of antisense oligonucleotides to T cells

PROJECT SUMMARY
Antisense oligonucleotides (ASOs) are promising drugs given their potential to modify expression of disease-
related genes, including those previously considered ‘undruggable’. Despite their clinical potential, their success
has been limited to hepatic, muscular and neurodegenerative conditions due to limitations with delivering ASOs
to tissues other than liver, muscle and the central nervous system (CNS), which are tissues with either rich
distribution of ASOs or specific delivery methods. Unfortunately, applications to immunological conditions or
conditions that could benefit from immuno-modulation (e.g., cancer, vaccines) have been limited due to the lack
of effective tools to deliver ASOs to immune cells in vivo, in particular to T cells. Accordingly, delivery tools that
could enhance the efficiency and specificity of ASO delivery to T cells remain a critical unmet need.
To address this critical need, ABS is developing a modular delivery platform to target ASOs specifically to T cells
utilizing conjugated mono-specific monoclonal antibodies (mmAbs) against T cell-specific cell surface receptors.
mmAbs are highly specific antibodies that have been screened against the human proteome and selected for
their exclusive binding to the target protein. Such selectivity screen is not usually employed in the development
of monoclonal antibodies, resulting in antibodies that bind to other proteins besides their intended target, thereby
enhancing potentially toxic effects due to off-target binding. Accordingly, the mmAbs proposed here have the
potential to enhance delivery of ASOs to T cells while reducing potential toxic effects of the antibody conjugate.
ABS’ T cell-specific delivery platform takes advantage of the T cell-predominant expression of the Programmed
Cell Death Protein 1 (PDCD1, PD1, CD279) and Interleukin 2 Receptor Subunit Beta (IL2RB, CD122). Besides
their T cell-predominant expression, their biological roles in T cells make them attractive candidates. PDCD1 is
highly expressed in tumor-infiltrating T cells and mediates suppression of these tumor-reactive T cells, thereby
hindering their efficacy to kill cancer cells. Accordingly, -PDCD1 antibodies could have a dual role in enhancing
tumor reactivity by directing immuno-modulatory ASOs to these critical cells, while also relieving the PDCD1-
mediated suppression of tumor-reactive T cells. IL2RB promotes receptor-mediated endocytosis in T cells, and
here we leverage this function to target and drive internalization of the conjugated ASO specifically in T cells.
The goal of this Phase I proposal is to test the efficiency and specificity of -PDCD1 and -IL2RB mmAbs to
deliver the conjugated ASOs to T cells ex vivo and in mice. Successful completion of this goal will validate the
utility of ABS’ T cell-specific delivery platform to deliver ASOs to T cells in vivo. This modular delivery platform
will have broad impact on human health given its wide applicability for treatment of cancers, immunodeficiencies,
autoimmune and infectious diseases, and applications in vaccine development. In the ensuing Phase II proposal,
we will create a mono-specific nanobody of the optimal mmAb to further improve its therapeutic index, and test
its efficacy and safety to deliver ASOs to T cells in mice and nonhuman primates.

Public health relevance
PROJECT NARRATIVE Antisense oligonucleotides (ASOs) are promising drugs for treatment of genetic diseases but applications to immunological conditions have been limited due to the lack of effective tools to deliver ASOs to immune cells in vivo, in particular to T cells. To address this critical need, ABS is developing a modular delivery platform to target ASOs specifically to T cells by utilizing conjugated mono-specific monoclonal antibodies (mmAbs) against T cell- specific cell surface receptors. Work proposed here will establish the efficiency and specificity of the mmAb conjugates to deliver ASOs to T cells in relevant ex vivo and in vivo models; if successful, this delivery platform will have broad impact on human health by empowering the specific delivery of ASOs to T cells to treat a wide array of immunological conditions, among them autoimmune diseases and immuno-oncology.